Administrative Core

Project Description (Core A): Core A is the administrative center of PARC that provides basic organizational
and administrative support for all other cores. In the next grant period, the Administrative and Research Support
Core will be directed by H-P Kohler and N Coe as Multi-PIs, representing respectively the School of Arts and
Sciences (SAS) and the Perelman School of Medicine (PSOM), PARC’s two institutional partners. The adminis-
trative support in Core A has been structured to provide support for this new institutional structure and leadership
of PARC, as well as for PARC’s expanded and more multidisciplinary set of Research Associates, PARC’s newly-
introduced research themes (Core O) and External Innovative Networks Core (Core C), PARC’s enlarged Program Development (Pilot) Core (Core B), and the newly-proposed External Research Resources Support and
Dissemination Core (Core D). The overall goal of Core A is to provide efficient and cost-effective administration
for PARC’s new institutional structure and the implementations of PARC’s mission of stimulating and supporting
cutting-edge multidisciplinary research on a broad range of NIA research priorities outlined in NIA RFA-AG-20-001 “Centers on the Demography and Economics of Aging.” The Specific Aims of Core A include: (1) Support
the leadership of PARC (Directors/Multi-PIs, Executive Committee, and External Advisory Board) and coordinate
the functioning of PARC, especially in light of PARC’s new institutional structure, including the collaboration
between SAS and PSOM, and the SAS/PSOM/other Penn Schools’ departments and research centers where
PARC Research Associates are located and with which PARC has partnerships. (2) Provide specific staffing and
administrative support for the activities of the other PARC cores: Program Development (Pilot) Core (Core B),
External Innovative Networks Core (Core C), and the External Research Resources Support and Dissemination
Core (Core D). (3) Maximize the efficiency of funding for demography and economics of aging research by
minimizing the financial and time burdens by providing administrative support services associated with research
projects and new grant applications.

Public health relevance
Project Narrative/Public Health Relevance (Core A): Interdisciplinary, co-operative research to advance knowledge in the demography and economics of aging requires an adaptive scientific infrastructure. The Population Aging Studies Center at the University of Pennsylvania, along with this Core A, provides an intellectual platform at the crucial juncture of the behavioral, social, and health sciences. The accounting and analytic frameworks of PARC, anchored in demography and health economics, provides insights to help meet the research and evidence needs to promote successful and equitable aging for individuals, and to inform effective health policy responses in aging societies, in the U.S. as well as globally.